Effect of Extracellular Citrate on Neuronal Excitability in SLC13A5 Epilepsy

Project Summary
SLC13A5 Epilepsy, or developmental epileptic encephalopathy 25 (DEE25), is a genetic form of
epilepsy characterized by severe multi-focal seizures within the first 24 hours of birth. This disorder is caused
by bi-allelic mutations in the SLC13A5 gene, which encodes a sodium citrate co-transporter (NaCT) that
mediates citrate import across the plasma membrane. Though there is currently limited understanding of the
complete disease spectrum and lack of comprehensive characterization, studies have demonstrated that
patients with SLC13A5 Epilepsy exhibit elevated citrate levels in both the cerebrospinal fluid and plasma.
Given the function of the SLC13A5 protein in citrate import and regulation, it is hypothesized that SLC13A5
deficiency leads to the accumulation of extracellular citrate. Studies have found the liver and brain express
high levels of SLC13A5, but the tissue-specific source of excess citrate and its impact on neuronal excitability,
and subsequent epileptogenesis, are unknown.
I will draw on years of translational neuroscience experience in my sponsor’s laboratory to understand
the relationship between extracellular citrate levels and neuronal excitability. In mice, homozygous loss of
SLC13A5 (SLC13A5-/-) is associated with epileptiform discharges in mouse electroencephalography.
Preliminary data from our laboratory has found that increasing levels of extracellular citrate lead to increased
interictal discharge events in local field potential recordings from both wild-type and SLC13A5-/- mouse brain
slices. Based on this data, I hypothesize that elevated citrate levels, secondary to tissue-specific SLC13A5
deficiency, will increase overall neuronal excitability, thereby contributing to epileptogenesis.
To test this hypothesis, I will examine the impact of SLC13A5 deficiency in tissues where SLC13A5 is
most highly expressed by combining advanced imaging with traditional electrophysiology. In Aim 1, I will
identify the tissue(s) where aberrant SLC13A5 expression leads to epileptogenesis using mouse
electroencephalography and quantitative PCR. In Aim 2, I will assess the impact of elevated extracellular
citrate on neuronal excitability using whole-cell patch-clamp electrophysiology and liquid chromatography-mass
spectrometry of mouse bodily fluids. In Aim 3, I will quantify neurotransmitter levels secondary to SLC13A5
deficiency with high-speed glutamate imaging. Overall, these experiments will establish the role of citrate in
abnormalities of neuronal excitability.
My long-term goal for this award is to transition into a career as a physician-scientist studying and
treating epilepsy. The sponsor team will share their expertise in translational epilepsy research, clinical
evaluations, and career development. Further training will be acquired from workshops and conferences, both
at and outside of Brown University, in addition to both national and international conferences. Overall, this
proposal will provide research and clinical training in addition to professional development.

Public health relevance
PROJECT NARRATIVE SLC13A5 Epilepsy is a rare genetic epilepsy caused by mutations in the SLC13A5 citrate transporter protein. Elevated citrate levels have been observed in these patients, but the effect of citrate on the nervous system are not well understood. I will use mouse models to investigate the relationship between citrate levels and brain excitability to improve our understanding of SLC13A5 Epilepsy and its underlying mechanisms.